Infectious Disease and Basic Microbiological Mechanisms

Infectious diseases and microbiology continue to be areas of pivotal importance in health care research.
Infection remains a major cause of mortality worldwide and poses serious problems of both individual and
public health concern in the United States. Antibiotic resistance occurs at an alarming and increasing rate
among all classes of mammalian pathogens. Moreover, diseases once thought to be near eradication from the
developed world—for example, tuberculosis, cholera, and rheumatic fever—have rebounded with renewed
intensity. Currently in its 40th year, the Infectious Disease and Basic Microbiological Mechanisms training
program maintains as its primary goal the training of scientists who have a career goal of solving medically
relevant problems and who elect rigorous laboratory or epidemiologic training in any of the Harvard adult
infectious disease programs or other Harvard-based institutions participating in this program. Over the past 40
years, the program has successfully trained leaders in academic medicine and investigators who have made
important contributions to the field.
In this competing renewal application, we propose an additional five years of funding and to maintain the
training program at its current level of seven postdoctoral trainees slots per year. We will use these slots to
provide support directly to selected infectious disease physician fellows during mentored research, and to also
provide support to selected Ph.D. trainees in Harvard Medical School infectious disease and microbiology
laboratories focused on areas that have significant clinical relevance, so as to support the rich research
training environment for physician-scientists within these laboratories and to provide these Ph.D. trainees
intensive exposure to medically-trained clinically-active researchers. Training will include a minimum of two
years of mentored research with hands-on in-laboratory training, appropriate advanced non-degree-granting
post-graduate coursework, attendance and participation of trainees at regular meetings and seminars of direct
relevance to infectious disease and microbiology research, including an annual training program retreat, and
instruction in the preparation of competitive proposals for funding, with a particular emphasis on applications
for K and other career development awards, including foundation awards. The specific aims are as follows:
1. To acquire sufficient training in basic laboratory or epidemiologic techniques and approaches to
conduct effective cutting-edge research into relevant infectious disease problems;
2. To foster the creation of important scientific contributions by means of strong and longitudinal
mentorship by program faculty; and
3. To develop a primary research focus and a broad understanding of infectious diseases and
microbiology, so as to both enable novel interdisciplinary research and lead to independence.!

Public health relevance
The Infectious Disease and Basic Microbiological Mechanisms training program continues to train postdoctoral trainees as independent physician scientists and Ph.D. scientists able to recognize and answer clinically relevant questions in the fields of infectious diseases and microbiology. This training program is especially important now, as we witness the emergence of new infectious diseases, the continued increase in illness due to antibiotic-resistant pathogens, and the development of revolutionary scientific technologies and approaches that have the potential to address these and other issues in the field.